Modular Synthesis of 1,2-Azaborines via Boron-mediated Strain-release Reductive Cyclization

Abstract: As an emerging class of bioisosteres of aromatic compounds, 1,2-azaborines have
received increasing attention in drug discovery. However, the current synthesis of 1,2-
azaborines encounters substantial difficulties, including how to access poly-substituted 1,2-
azaborines and BN-heteroarenes, how to avoid using expensive catalysts and handling
sensitive intermediates, how to increase modularity and scalability, etc. Here, we propose to
develop a boron-mediated strain-release reductive cyclization (BSRC) strategy to address these
accessibility and practicality challenges. Our objective, in the proposed funding period, is to
establish the BSRC method for preparing multi-substituted 1,2-azaborines and 4,9-BN-
quinolines from readily available cyclopropyl ketones and aziridyl pyridines (AZPs), respectively.
Specifically, we will conduct the reaction discovery, method optimization, scope exploration, and
mechanism studies. The proposed research is expected to offer a new approach for streamlined
synthesis of 1,2-azaborines, which, in turn, should accelerate preparation of novel
pharmaceutical analogues and expand the chemical space for drug discovery.

Public health relevance
Public Health Relevance Statement: Arenes and heteroarenes are commonly found in approved small-molecule drugs. 1,2-Azaborines hold great promise of serving as biologically equivalent moieties to arenes in drug design; however, they are difficult to be prepared efficiently. The outlined proposal aims to enable a new catalytic method for preparing various 1,2-azaborines and BN-heteroarenes in a streamlined and modular manner, which is expected to address the long-standing accessibility and practicality issues of developing 1,2-azaborine- based pharmaceutical compounds.